BP-BRAIN-ENDURE at Hunter and NYU

Project Summary/Abstract
Diverse racial and ethnic groups, as well as individuals with disabilities or from socially, economically, or
educationally disadvantaged backgrounds are underrepresented in neuroscience. Hunter College of the City
University of New York (CUNY) and New York University (NYU) recognize that increasing the number of highly
qualified neuroscientists from these underrepresented populations is integral to our future as academic and
research institutions. Hunter College and NYU aim to increase the number of well-trained, diverse
neuroscientists. The newly named “BP-BRAIN-ENDURE at Hunter & NYU” program proposes to capitalize on
and expand on the objectives and success of our first 13+ years of ENDURE funding, which has produced a
total of 76 program graduates. Among our 76 graduates, 62 (82%) have applied to graduate school in the
neurosciences. Most impressively, 94% of our trainees (58 out of 62) who’ve applied to graduate school have
been accepted to some of most prestigious neuroscience doctoral programs in the country, including Johns
Hopkins, UC-Berkeley, UCSF, UCLA, CalTech, Georgetown, NYU, U. Michigan, U. Pennsylvania, Stanford,
Brown, Cornell, Yale and Harvard. Eleven (11) of our program graduates have been awarded the NSF
Graduate Research Fellowship, with several others receiving Honorable Mention. The overall goal of the
present application is to continue to develop and refine a neuroscience training program at Hunter and NYU
that will encourage and prepare students from diverse backgrounds to enter into and succeed in neuroscience
Ph.D. programs. To achieve this goal, our program has developed a research-educational partnership with five
outstanding T32-awarded universities—New York University, Brown, the University of Michigan, Vanderbilt, and
Yale. These partnerships will expose a total of twelve (12) BP-BRAIN-ENDURE scholars from Hunter College
and NYU (6 from Hunter; 3 from NYU) each year to a research-intensive curriculum and an environment of
excellence and active research. During the proposed funding period, five (5) specific aims are outlined as part
of our overall Research and Education Plan: (1) To recruit outstanding undergraduate students from diverse
backgrounds who are dedicated to pursuing graduate study in neuroscience; (2) To provide training in a
diverse range of neuroscience research questions and skills through multiple placements with actively funded
neuroscientists; (3) To implement a curriculum rooted in our students’ neuroscience research experiences that
enhances their academic and professional development; (4) To facilitate effective mentoring by our program
faculty; and (5) To maintain an effective Administrative Core to support our students’ professional development,
evaluate program effectiveness and disseminate best practices. Our measurable objectives during the
requested funding period include: (1) attaining 85 to 90% acceptance of trainees to graduate school programs
in neuroscience; (2) improving our students’ quantitative, scientific writing and oral presentation skills; and (3)
enhancement of mentoring quality and support.

Public health relevance
Relevance Statement Hunter College of the City University of New York, New York University, Brown University, the University of Michigan, Vanderbilt University, and Yale University recognize the need to increase the number of highly qualified neuroscientists from diverse backgrounds. Through active partnerships between these institutions, we aim to continue our successful undergraduate neuroscience training program that prepares students from diverse backgrounds to enter into and succeed in PhD programs in the neurosciences.